ANTIPYRETIC EFFICACY AND SAFETY OF CHEWABLE VS LIQUID IBUPROFEN

This study was an efficacy and safety study of chewable ibuprofen in pediatric patients. There were no adverse reactions during the study period.